Non-coding RNA in stem cell biology

PROJECT SUMMARY
Non-coding RNA is an important regulator of gene expression and genomic stability. Such processes are
particularly important in pluripotent stem cells where tight regulation of maintenance, division, differentiation,
and (epi)genetic stability is crucial for a favorable outcome. Currently, there are major gaps in our
understanding of how pluripotent stem cells are stably maintained long-term, or make the transition to
differentiation. In our research program we leverage the in vivo study of a tightly controlled population of long-
lived adult pluripotent cells, the neoblasts of the planarian Schmidtea mediterranea, to reveal the regulatory
mechanisms surrounding pluripotency.
This proposal concerns the role of non-coding RNA in the protection of the stem cell state, and the facilitation
of the transition out of pluripotency during differentiation. We focus on the role of PIWI-interacting RNAs
(piRNAs), and their binding partners the PIWI proteins. These small non-coding RNAs are essential for stem
cell function, in particular in early embryos and regenerating animals. While piRNAs are best known for their
silencing of transposable elements (TEs), we previously found that the piRNA pathway regulates a much
broader range of non-coding transcripts in stem cells, and that many such transcripts are processed into
piRNAs, raising the question of how the piRNA response remains contained. In this next period we will
therefore address how source transcripts for the piRNAs are generated and recognized, and how this process
balances the need to maintain flexibility to respond to novel invading elements with the need to keep the
response away from important genes. Further we will analyze whether and how the piRNA pathway interacts
with other non-coding RNA regulatory pathways that function in the stem cells.
Following up on our previous findings on the role of PIWI proteins in the chromatin regulation around cell
differentiation, we will identify the proteins involved in depositing histone modifications at piRNA target sites in
the genome, and determine how the local chromatin changes at piRNA target sites propagate to failure of
chromatin re-arrangement during differentiation. This is a fundamental question that is difficult to address in
less prolific stem cell systems. Further, we will investigate a potential direct relationship between piRNA
targeting and DNA damage repair.
Together, the proposed experiments will provide deep mechanistic insights in the generation, interactions, and
effects of piRNAs, which are essential for long-term stem cell function. Our research program addresses big
questions in stem cell biology as well as molecular biology, spanning many layers of regulation. This work will
have broad impact on our understanding of the regulation of pluripotent cells, and in the long run will contribute
to the safe use of pluripotent cells in therapeutic applications.

Public health relevance
PROJECT NARRATIVE Pluripotent stem cells hold vast potential for therapeutic applications, but need to be tightly controlled to avoid catastrophe. Goal of this project is to elucidate how piRNAs and chromatin regulation collaborate to maintain long-term stability of pluripotent stem cells and of stem cell differentiation in vivo. This project will have broad impact on our understanding of pluripotency and of regulation of genomic stability in general, with implications for fertility, birth defects, aging, cancer, and therapeutic applications of stem cells.